Bioinformatics Discovery of Anti-CRISPR Operons in Human Gut Microbiome

PROJECT SUMMARY
Various bacterial CRISPR-Cas systems and their variants have been engineered and repurposed for gene
editing in animals, plants, and microbes since 2013. However, the current CRISPR-Cas genome editing tools
are not perfectly safe to use. This is primarily due to the lack of an effective brake system and the off-target
effect that may create unwanted cuts in the genome. Different strategies are being developed to reduce off-
target effect and make CRISPR-Cas safer to use.
A fact often overshadowed by the great success of genome editing is that, in the microbial world, CRISPR-Cas
is an adaptive anti-viral immune mechanism present in ~50% of bacterial and ~90% of archaeal genomes. As
a counterstrategy, anti-CRISPRs are produced by viruses and proviruses, as an anti-anti-viral mechanism,
to inhibit the CRISPR-Cas systems of their prokaryote hosts. Thus, as the naturally occurring inhibitors of
CRISPR-Cas, anti-CRISPR (Acr) proteins have obvious advantages to be used for developing safer and more
controllable CRISPR-Cas genome editing technologies.
The objective of this project is to develop a genomic context-based tool (AOMiner) for bioinformatics data
mining of new Acr operons in human gut microbiome and virome. The significances of this project include: (i)
it will enhance the experimental characterization of new anti-CRISPRs, which is fundamental to the
understanding of phage-host interactions, and further to the development of novel phage-based technologies
to combat pathogenic bacteria and infectious diseases; (ii) it will deliver new open source computer programs
and online databases to provide novel anti-CRISPR candidates to be exploited for building safer and more
controllable CRISPR-Cas genome editing tools.
We recently developed AcrFinder (http://bcb.unl.edu/AcrFinder/), a bioinformatics software package for
automated discovery of Acr operons, primarily based on sequence homology search. However, its ability to
identify new Acrs is limited because it is largely based on homology search. The innovation of this project is
that AOMiner (http://bcb.unl.edu/AOMiner) will implement a genomic context-based algorithm focusing on
discovery of new Acr operons instead of Acr proteins. Additionally, this project will be the first large-scale
genome mining for Acrs operons from human gut microbiome and virome, which will be developed into a
gutAO database (http://bcb.unl.edu/gutAO).
In summary, this project will deliver a suite of bioinformatics software tools in the form of open-source
computer programs and online databases to assist the characterization of novel anti-CRISPRs.

Public health relevance
PROJECT NARRATIVE Anti-CRISPRs are produced by viruses and proviruses to inhibit CRISPR-Cas systems of their prokaryote hosts. The current bacteria-derived CRISPR-Cas genome editing tools suffer from the lack of an effective brake system and the off-target effect that may cause unwanted cuts in the target genome. Developing machine learning-based genome mining tools for anti-CRISPR discovery will contribute to: (i) the fundamental understanding of phage-host interactions, (ii) the development of safer and more controllable CRISPR-Cas genome editing tools, and (iii) the development of novel phage-based technologies to combat pathogenic bacteria and infectious diseases.